Advances in Sleep and Circadian Science

Abstract
The Sleep Research Society (SRS) is dedicated to promoting and advancing the scientific understanding of
sleep and circadian rhythms across the translational spectrum, from their molecular regulation across species,
to their cross-generational transmission through genetic, epigenetic, cultural, and social forces, to their impact
on health and functioning. Inexorably linked, sleep and circadian rhythms entrain and sustain physiological and
behavioral processes critical to survival, such as immune, psychiatric/neurologic, metabolic, and motor functions.
In 2017, circadian biologists Michael Young, Michael Rosbash, and Jeffrey Hall were awarded the Nobel Prize
in Physiology or Medicine for their discoveries that propelled our understanding of the molecular mechanisms
controlling circadian rhythms. Advances in the molecular underpinnings of circadian rhythms have, in turn,
informed our understanding of the cellular and molecular mechanisms of sleep. Yet, despite the physiological
and behavioral links between sleep and circadian rhythms, the fields of sleep and circadian science have evolved
somewhat independently, limiting their reach and scope. The SRS seeks to redress this issue by organizing a
unique transdisciplinary sleep and circadian science conference to promote interdisciplinary cross-talk, extensive
discussion of cutting-edge science, identification of gaps in knowledge and opportunities to catalyze
transdisciplinary research, and specialized programming for trainees and early stage investigators, who
represent the future of this important transdisciplinary field.

Public health relevance
Project Narrative The Advances in Sleep and Circadian Science meeting is scheduled for February 14-17, 2025 in Clearwater, Florida. This small, single-track meeting will include cutting-edge research that bridges, or has great potential to bridge, sleep and circadian science. Each session will highlight the research of high-impact sleep and circadian scientists and conclude with discussion, moderated by an eminent sleep and/or circadian scientist, who will be charged with eliciting from the group critical gaps in knowledge, opportunities, and important next steps that could catalyze truly transdisciplinary sleep and circadian science. Sessions are focused on the control and outputs of sleep and circadian rhythms across the lifespan and translational spectrum including the genetic, computational and clinical perspectives of biomarkers, emerging therapeutics, fluid dynamics in the brain, non- neural pathways, light exposure, substance use, childhood development, and longevity/aging. Separate plenary sessions, including one on harnessing artificial intelligence for sleep and circadian research are also planned, as well as daily trainee focused sessions. Eminent and emerging sleep and circadian scientists have been invited to participate in this transformative meeting. Already confirmed are Luis de Lecea, Lucia Peixoto, Cliff Saper, Yang Dan, Azizi Seixas, Karen Gamble, Morgan James, Sarah Honaker, Lauren Harstein, Kathryn Roecklein, Timothy Brown, John Hogenesch, Lisa Marshall, Kenneth Diller, Jen Strahle, Carla Green, Amita Sehgal, John O’Neill, Ashley Ingiosi, Laura Fonken, Alec Davidson, Jeffrey Iliff, Ben Julian Palanca, Chris Depner, Gianluca Tosini, Jimmy Dooley, Ryan Logan.